AFRICAN AMERICAN STUDY OF KIDNEY DISEASE

To determine whether various antihypertensive medications and whether different levels of blood pressure control will prevent worsening of kidney disease in African Americans with early evidence of kidney damage from hypertension.